Project-002

The overall goal of HIPC3 Project 2 is to identify human molecular signatures induced by HIV-1
vaccines and adjuvant formulations that are of potential relevance to protection against HIV-1
infection in diverse populations. Our proposed investigations will focus on three areas where
critical insights are needed: 1) comprehensive assessment and comparison of the quality and
enhanced potency and durability of immune responses following immunization with a soluble
native-like Env trimer formulated with different adjuvants, 2) evaluation of lymph node germinal
cell activities and B cell function and phenotype that have the potential to initiate development of
HIV-1 broad neutralizing antibodies, and 3) advance high-throughput systems to interrogate the
HIV-specific T cell repertoire following vaccination and identify profiles that may associate with
immune protection in partially efficacious vaccine trials. Embedded in these studies will be
selected analyses of response signatures in unique tissue sources and in diverse populations.
These investigations will accelerate progress toward an effective vaccine by probing innate and
adaptive immune responses at an unprecedented level in humans.